DISSEMINATION OF BIOL MASS SPECT TECHNOLOGY &APPLICATIONS AT SCIENTIFIC MEETING

Mass spectrometric discoveries in the last decade underpin a revolution in the study of bio-macromolecules and their cellular biochemistry and physiology. It is of utmost importance to bring these remarkable new experimental strategies to the attention of the biological and clinical research communities. Meetings attended include the 46th ASMS Conference on Mass Spectrometry and Allied Topics, Orland, FL, May 31-June 4, 1998; the ASBMB meeting, Washington, D.C., May 16-22, 1998; and the ABRF meeting in San Diego, March 21-24, 1998. kD 141